CVD Epidemiology Training Program in Behavior, the Environment and Global Health

7. Project Summary
This proposal will fund the NHLBI CVD Epi Training Program in Behavior, the Environment, and
Global Health, critically important scientific disciplines that remain under-represented in NHLBI
training. This Program will train 2 pre-doctoral and 6 post-doctoral trainees each year in the rich
academic environment of the Harvard T.H. Chan School of Public Health and affiliated institutions
locally and worldwide, bringing together outstanding faculty Mentors to provide integrated and
interdisciplinary experiences and collaborative interactions, specialized curriculum with core and
elective coursework, nondidactic practical career training, individual candidate training plans, and
ongoing Program evaluation. Cutting-edge didactic training and mentoring will create a new
generation of highly skilled and enthusiastic investigators to study the impact of behavioral and
environmental risk factors on cardiometabolic diseases; to elucidate the cultural norms and biologic
and sociologic pathways that modify these risk factors; and to understand and utilize the full set of
epidemiologic, interventional, environmental, and policy tools to design, implement, and evaluate the
most effective individualized, community, and policy interventions to reduce impact of harmful risk
factors, facilitate expansion of protective behavioral and environmental factors, and attenuate or
reverse the alarming global trends in cardiometabolic diseases. Training will include modern
methodological and analytical techniques required to study the intersections of cardiometabolic
diseases with Behavior, including observational epidemiology and interventions across the life cycle;
the Environment, including airborne and environmental toxins, social risks, and physical (built)
environment; and Global Health, including observational epidemiology, demography, comparative risk
assessment, and controlled interventions at both individual, community and healthy system levels.
This Training Program adds considerable strength and depth to the NHLBI’s commitment to
understanding the behavioral and environmental determinants, preventive measures, and treatments
of cardiovascular and metabolic diseases in both developed and developing nations.

Public health relevance
8. Project Narrative Training a new generation of investigators to understand how behavioral and environmental risk factors impact cardiovascular and metabolic diseases, and how to cost-effectively and sustainably modify these factors, is among the most important scientific tasks of our time. These are global challenges, as changing behaviors and environmental risks are rapidly increasing cardiovascular and metabolic diseases worldwide and widespread use of costly new drug- and device-related treatments may not be practical or cost-effective.